Research Conference to develop a national healthcare workforce wellness research agenda for AHRQ in the Learning Health System (LHS) program

Project Summary/Abstract
The AHRQ-sponsored conference series on “Developing a research agenda for wellness within the LHS
framework” has an overarching goal of creating a foundation for development of the next generation of
healthcare worker (HCW) wellness scholars and equipping them with tools to carry out a structured research
agenda on HCW reactions to challenging work environments. These conferences will convene a
multidisciplinary group of stakeholders studying HCW wellness and work culture. Our objectives are to identify
promising strategies to study HCW wellness and develop competencies required for this rigorous area of
scholarship. The Year 1 conference will develop the workforce protection research agenda, while the Year 2
conference will assemble stakeholders and scholars to disseminate findings and build career development in
wellness into LHS programs. A “learning community” established before Conference 1 will sustain progress
between meetings and after meeting #2. The conferences will focus on Research Development, integrating
themes related to AHRQ priority areas of research design, dissemination, implementation, research training
and career development. A core group of wellness scholars called “Eisenberg Scholars”, after AHRQ’s former
leader John Eisenberg, will be selected and invited to Conference 2 to populate and catalyze a new research
community devoted to this work. Applicability to priority populations and equity in research will be core aspects
of each activity.

Public health relevance
Project Narrative The AHRQ-sponsored conference series on “Developing a research agenda for wellness within the LHS framework” has an overarching goal of creating a foundation for development of the next generation of healthcare worker (HCW) wellness scholars and equipping them with tools to carry out a structured research agenda on HCW reactions to challenging work environments. These conferences will convene a multidisciplinary group of stakeholders studying HCW wellness and work culture. Our objectives are to identify promising strategies to study HCW wellness and develop competencies required for this rigorous area of scholarship.